Administrative Core

Administrative Summary
The Administrative component of the Pediatric Center of Excellence in Nephrology (PCEN) is charged with
oversight and organization of all of the activities of Center. The Program Director, R. Ariel Gomez will be
responsible for the scientific coordination, the direction of research emphasis and the overall administration
of the Center. Drs. Patricio Ray and Maria Luisa Sequeira-Lopez, senior principal investigators (PIs) of two
of the Center projects will assist him in scientific and administrative matters including the Pilot and Feasibility
(P&F) program (Dr. Ray) and the Enrichment program (Dr. Sequeira-Lopez). The Executive committee,
composed of Dr. Gomez and all the project PIs with the internal and external advisory committees will
oversee the P&F program, the Enrichment program and the functioning of the Core. The internal and
external advisory committee members are experts in the central scientific theme of the Center. Those
advisors will visit and evaluate the whole program each year and make recommendations regarding the
suitability, funding and continuation of P&F projects and the direction of the center. The Administrative
component will continue to maintain a fully developed website that describes the Center, highlights the
research accomplishments of individual projects and the Core in Single Cell Epigenomics, Transcriptomics
and Bioinformatics, advertises the call for applications to P&F awards (in coordination with the 2 other
PCENs), and publicizes the seminars and symposia provided through the Enrichment program.
Furthermore, all the opportunities and activities will be advertised in the PCEN Twitter and Facebook
accounts. The University of Virginia provides extensive research facilities with numerous additional core labs
to guarantee an exceptional environment for the research activities of the Center investigators. In further
support of the Center, the institution has committed funds for salary, reagents and educational enrichment
activities. The PCEN will continue to collaborate with the adult Nephrology Division via a Pediatric and Adult
Nephrology U2C/TL1 training grant, with the Integrated Translational Health Research Institute of Virginia
(iTHRIV), the Center for Public Health Genomics, the new School of Data Science, the Cardiovascular
Research Center (T32) and all the O’Brien and PCENs through the NOCKS series as well as establishing
common PCEN workshops and annual symposia